TREATMENT OF ALS--IMMUNOSUPPRESSION WITH IV PLUS ORAL CYCLOPHOSPHAMIDE

The primary aim of this study is to determine whether powerful immunosuppression produced by intravenous and oral cyclophosphamide is effective in halting or significantly slowing the progressive course of ALS.